Prioritized Assembly in Protein Conformational Search

[unreadable] DESCRIPTION (provided by applicant): An efficient and effective conformational search method is essential for solving the computational protein folding problem. Prevalent conformational search methods are fast but incomplete. Proposed here is an exhaustive enumeration-based search method that combines a focus on the most promising search paths with a complete coverage of a discretized conformational space. The search is a prioritized building-up process: Structural templates of low energy are generated for short segments of the chain. Structural elements, either templates or individual residues, are added to a growing conformation one at a time. The addition of a structural element is prioritized on its energetical contribution to the conformation as a whole. Simple templates such as tight turns, helices or strands form packing clusters such as hairpins and beta-sheets. A finished conformation is often the assembly of packing clusters. Search efficiency is achieved by pruning unpromising search branches at each building-up step. [unreadable] [unreadable] In phase I, the architecture of prioritized assembly-based search has been implemented, demonstrating the feasibility of the approach. Phase II will develop algorithms for computing tight lower bounds of conformational energy, which are crucial for effective branch-and-bound search, and for integrating exhaustive enumeration with minimization. Phase III, with peer-to-peer parallelization, will develop a comprehensive conformational search program for computational protein folding. [unreadable] [unreadable]